N-acetylserotonin alleviates neurotoxicity in alcohol misuse following TBI

Traumatic brain injury (TBI) and comorbid alcohol use disorder (AUD) cause heavy medical, economic, and
social burdens. TBI drives the escalation of alcohol intake in TBI patients and animal models. One challenge is
that TBI and comorbid AUD (alcohol misuse following TBI) is difficult to manage with current treatment options.
Another challenge is that the molecular mechanisms underlying alcohol misuse following TBI are lacking. Thus,
it is urgently needed to explore novel therapies and molecular mechanisms for AUD following TBI. We and others
reported that N-acetyl-serotonin (NAS) offers protection by targeting neurotoxicity and inflammation in various
tissue injuries. However, it is unknown whether NAS alleviates AUD following TBI. The central hypothesis of this
translational project is that NAS mitigates TBI-induced alcohol consumption. The overall goal is to develop a
novel NAS therapy to alleviate TBI-increased alcohol intake and preference and elucidate its protective
mechanisms by regulating brain-derived neurotrophic factor (BDNF), tyrosine receptor kinase B (TrkB)/Akt
pathway, and inflammation. This study is supported by preliminary data and prior research: 1) NAS is a potent
agonist of TrkB, and the BDNF/TrkB pathway plays an important role in alcohol consumption. 2) we and others
report that NAS inhibits neurotoxicity in cultured neurons and offers protection in animal models of cerebral
ischemia and retinal ischemia-reperfusion. 3) we and others reported that NAS protects hepatic cell apoptosis
and hepatic ischemia-reperfusion injury and acts on circadian rhythm by TrkB activation. 4) our preliminary data
suggest that NAS alleviates TBI-induced alcohol intake and preference, cognitive decline, and neurobehavioral
deficit in a few mice in vivo and prevents neurotoxicity in scratch- and ethanol-treated cultured neuronal cells, a
cell injury model of alcohol use following TBI in vitro. 5) we show that NAS reduces interleukin-1β (IL-1 and IL-
6 releases in scratch- and ethanol-treated astrocytes, another cell injury model of alcohol use following TBI, and
6) we found that NAS alleviates BDNF reduction in TBI-induced alcohol consumption exposed mice.
Aim 1 will test whether NAS alleviates TBI-induced alcohol consumption, neurodegeneration, and cognitive
and neurobehavioral impairments in mice and determine whether TrkB deficiency, at least partly, reduces NAS’s
benefits in TrkB knockout mice. Aim 2 will determine whether the protective mechanisms of NAS are mediated
by regulating BDNF expression, activating TrkB/Akt pathway, and inhibiting inflammation as well as the
regulation of BDNF/TrkB/Akt pathway of NAS are mediated by activation of TrkB using TrkB knockout mice.
The success of this study will make an important contribution to drug discovery and pathogenesis for alcohol
misuse following TBI. Key strengths include: i) Usage of TBI, AUD, and TBI-induced alcohol intake and
preference animal models; ii) Extensive experience in the study of NAS in a variety of tissue injuries; and iii) A
strong team with interdisciplinary and complementary expertise and an excellent history of collaborative
publications in the fields of AUD, alcohol consumption, inflammation, neurotoxicity, and drug development.

Public health relevance
Project Narrative Traumatic brain injury and comorbid alcohol use disorder cause heavy medical, economic, and social issues. This project aims to identify a novel N-acetyl-serotonin therapy for traumatic brain injury-induced alcohol consumption and advance the understanding of the protective mechanisms by which N-acetyl-serotonin targets the BDNF/TrkB/Akt pathway and inflammation.